Resident Memory T cells in Chronic Kidney Disease

Project Summary
Chronic kidney disease (CKD) is a disorder with significant morbidity and mortality which affects millions of
Americans and shows no sign of improvement. Because there are no clinically approved therapeutics that can
halt or reverse the progression of CKD to end stage kidney disease, research is needed to elucidate novel
molecular and cellular targets. This project is based on the scientific premise that inflammation and fibrosis are
key components in the progression of CKD. While recent research has highlighted the importance of the immune
system in CKD, the specific contributions of resident memory T cells (TRMs) remain unknown. We have
established and validated an aristolochic acid (AA)-induced mouse model of CKD which mimics clinical CKD.
Five consecutive days of AA injections lead to a sustained decline in kidney function, indicated by reduced
glomerular filtration rate and increased serum creatinine six weeks later. Flow cytometry of kidneys reveals a
predominantly lymphocytic infiltrate within two weeks of the first AA injection, CD4 and CD8 T cells being the
most abundant. These T cells persist for at least 6 weeks, coinciding with the persistent decline in kidney function.
Moreover, a large population of T cells in the kidneys of these mice express pro-inflammatory and fibrotic
cytokines, as well as CD103, a hallmark epithelial adhesion molecule of TRMs. TRMs have been described as
contributors to unwanted inflammation in other chronic diseases and their presence has been descriptively noted
in human kidneys. Thus, our central hypothesis is that TRMs mediate the progression of CKD through an
inflammatory response that promotes kidney injury and fibrosis while inhibiting repair. The aims of this proposal
will 1) determine the activation status and cytokine profiles of TRMs as well as their contributions to kidney
inflammation and fibrosis; and 2) determine CD103’s necessity for T cell-epithelial adhesion and its regulation of
T cell localization to injured kidneys, as well as its necessity for the TRM pro-inflammatory state. To achieve
these goals, we will utilize genetic knockout models, adoptive immune cell transfer, flow cytometry,
immunofluorescence microscopy, and pharmaceutical interventions both in vitro and in vivo. Successful
execution of the proposed studies will illuminate basic mechanisms involved in CKD and could provide pre-
clinical evidence for novel targets in the treatment of CKD. This is in line with the mission of the NIDDK, as this
proposal focuses on the elucidation of treatments for progressive kidney disease. The laboratories of the
sponsors along with their expertise in nephrology and immunology will provide an ideal training environment to
carry out the proposed studies and advance the PI’s career. The training received will advance the knowledge,
critical thinking, technical, and professional skills that will be required for the PI’s transition into independent
academic research and establishment of his niche in the field of cardiorenal disease.

Public health relevance
Project Narrative Chronic kidney disease is a progressive, irreversible loss of kidney function affecting up to 37 million Americans and is a significant health burden with increased patient risks for cardiovascular disease, stroke, and early death. Despite the widespread use of therapies aimed at compensating kidney function, these treatments do not reverse chronic kidney disease and only delay the progression to its final stage, end stage kidney disease. The current proposal will elucidate the contributions of T cells to the inflammatory milieu of chronic kidney disease and investigate the mechanisms through which T cells localize to kidney tissue, providing preclinical evidence for potential therapies in the management of chronic kidney disease.